Hyperglycemia and Adverse Pregnancy Outcome Study-Cardiovascular Health of HAPO Offspring (HAPO CVH)

Project Summary
Halting the intergenerational transfer of cardiovascular disease (CVD) risk is a priority for NHLBI and the
American Heart Association (AHA). Yet, limited understanding around the timing, pathways, and mechanisms
underlying the observed associations between maternal gestational health and offspring cardiovascular health
(CVH) remains a significant barrier to developing targeted, timely interventions. We propose to leverage the
Hyperglycemia and Adverse Pregnancy Outcome (HAPO) Study cohort to substantially advance understanding
of the in utero origins of offspring CVH and CVD, as measured during the critical period of young adulthood. The
original HAPO study recruited ~25,500 women in 2000-2006 to prospectively and uniformly examine the
association of gestational glycemia, uncomplicated by treatment, with maternal and neonatal outcomes. Eleven
years later, 4,832 offspring returned to study effects of GDM on offspring adiposity and glycemia. We hypothesize
that there are significant independent associations of maternal adiposity, glycemia, BP, and lipids at ~28 weeks
gestation with CVH and arterial injury among offspring at age 18-25 years, and that DNA methylation (DNAm)
will be associated with upstream intrauterine exposures and downstream CVH and arterial injury. HAPO CVH
will include a comprehensive CVH assessment of 1,000 HAPO FUS offspring from 4 HAPO centers. We will
measure BP, adiposity, lipids, glycemia, and lifestyle behaviors, characterize total CVH with AHA’s ‘Life’s Simple
7’ framework, and obtain carotid ultrasonography to identify the earliest changes of subclinical CVD. We will also
analyze existing cord blood DNAm data and will acquire new epigenome-wide association data from young adult
DNA using the Illumina 850K chip. We will achieve our objectives through the following specific aims: Specific
Aim 1: Define associations of the in utero cardiometabolic milieu at ~28 weeks’ gestation with offspring CVH
and subclinical CVD in young adulthood. Hypothesis 1a: Poorer maternal gestational metabolic health is
associated with poorer offspring CVH (Co-primary outcome) in young adulthood. Hypothesis 1b: Poorer
maternal gestational metabolic health is associated with higher carotid IMT (Co-primary outcome), lower carotid
distensibility, and unfavorable carotid artery grayscale features in young adulthood. Hypothesis 1c: Poorer
maternal gestational metabolic health is associated with worsening of cardiovascular health from childhood to
young adulthood. Specific Aim 2: Examine the role of epigenetic mechanisms in the association of upstream
intrauterine cardiometabolic exposures and downstream CVH and subclinical CVD. Hypothesis 2a: Poorer
maternal gestational metabolic health is associated with differential DNAm in aging-related pathways (measured
as accelerated epigenetic aging) in cord blood and young-adult offspring. Hypothesis 2b : Poorer maternal
gestational metabolic health is associated with differential DNAm in specific cardiometabolic pathways in young-
adult offspring blood cells, and this differential DNAm partly statistically mediates the association of adverse
intrauterine exposures with later CVH status and carotid arterial injury in young adulthood

Public health relevance
Project Narrative The proposed study will encompass a comprehensive investigation of the cardiometabolic in utero environment and its association with cardiovascular health (CVH) and arterial injury in young-adult offspring. Findings will give insights into 1) the burden of poor CVH and arterial injury at this critical time of life when cardiovascular disease risk may progress and interventions may slow further progression, 2) timing for future interventional studies in pregnancy and markers to follow to assess effectiveness and 3) novel mechanisms of the passage of cardiometabolic risk from mothers to their children, allowing for potential new targets for intervention.